Visual Science Training Grant

Program Director/Principal Investigator (Last, First, Middle): Zhou, Z. Jimmy Abstract This application proposes to continue an integrative training program in visual science research at Yale University School of Medicine, with a special emphasis on visual neuroscience. The goal of this program is to foster interdisciplinary approaches to visual neuroscience that will interface with molecular genetics and clinical medicine in the areas of development, organization, function, degeneration, and regeneration in the eye and the central visual system. Fourteen faculty preceptors from six basic and clinical departments participate in this multidisciplinary program. These faculty members lead vibrant vision research programs in a vision research community at Yale that has undergone an exciting phase of revitalization and expansion, and that has attracted an increasing number of outstanding graduate students and postdoctoral fellows. The proposed training program offers both depth and breadth. The depth derives from its substantive focus on the neuroscience of the eye and the visual system. The breadth of the program derives from the diversity of approaches, spanning molecular, developmental, systems, cognitive and theoretical neuroscience, as well as from the range of experimental models used in these studies, spanning drosophila, zebrafish, rodents, and primates. Faculty interests range from retinal development and degeneration, retinal physiology and circuits to visual cortical function and visual behavior. Methodologies include cloning; cell culture; immunocytochemistry; in situ hybridization; gene transfection and transgenic technology, electron and two photon microscopy; optogenetics, patch-clamp and multielectrode recording; electroretinograph, optical imaging; biochemistry and molecular analyses; psycho-pharmacology; rodent, monkey and human behavior; in vivo extracellular recording in behaving animals; and fMRI and PET imaging in human subjects. Two predoctoral and two postdoctoral positions are requested. Trainees will be selected from a variety of backgrounds in biological sciences on the basis of their potential for excellence and leadership in research by an Executive Committee. Mentors are Ph.D.s and M.D.s. with NEI and other NIH institute grants or NEI related research foci. Training includes coursework, intensive research apprentice-ship, structured seminar programs, laboratory and departmental presentations of research progress, and instructions on responsible research conduct. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Zhou, Z. Jimmy Project Narrative The proposed program supports predoctoral and postdoctoral training in vision research in Yale Medical School, with an emphasis on visual neuroscience. The long term goal of this proposal is to foster career development of basic, translational and clinical vision research scientists. The program draws both from the tremendous research strengths of an expanding vision research community at Yale and from an excellent and diverse pool of trainee candidates. Trainees will participate in a rigorous curriculum of training that includes coursework, laboratory research, seminars, presentations, and teaching. The outcome of the training program will directly impact our understanding of the visual system and the treatment of devastating eye diseases and visual system disorders. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page